Neural circuits of cue and spatial representation in the dentate gyrus

Project Summary
Human patients with neurological disorders such as Alzheimer’s disease and age-related dementia commonly
show defects in spatial navigation which correlate strongly with memory dysfunction. Both of these functions are
thought to involve processing by the hippocampus and associated temporal lobe regions, which have been found
to exhibit pathological changes in these and other disorders of learning and memory. During spatial exploration
animals form an internal cognitive map of an environment by integrating online sensory input with information
about the animal’s movement through space, a process which involves the hippocampus. Yet it is still unclear
how different subregions of the hippocampus contribute to the integration of sensory cue and self-motion
information in the formation of a spatial map for navigation. The dentate gyrus (DG) is the initial stage of the
classical ‘trisynaptic circuit’ of the hippocampus, and receives its principal inputs from the lateral and medial
entorhinal cortex (LEC and MEC), which are proposed to carry information about sensory cues (objects) and
self-motion (space), respectively. Thus it has been suggested that as the first stage of hippocampal processing,
the DG integrates cue (“what”) and spatial (“where”) information to form discrete spatial representations such as
those found in place cells elsewhere in the hippocampus and which are proposed to underlie an animal’s overall
map of an environment. We have however recently documented strong sensory cue responses in a
subpopulation of dentate granule cells largely independent of spatial context (“cue cells”), in addition to spatially
integrating “place cells” independent of local cues. This suggests that cue and spatial information are kept
separate at the level of the DG. In this proposal we will examine the microcircuitry of cue and spatial
representations in the dentate gyrus using modern in vivo calcium imaging, population decoding, and optogenetic
circuit analysis combined with precise behaviors designed to isolate independent cue and spatial influences on
the dentate circuit. We will leverage these powerful techniques along with cutting edge analytical tools to test
the hypothesis that in the DG population, “cue cells” are driven primarily by the LEC and “place cells”
driven by the MEC. Furthermore, we will analyze the effect of local circuit mossy cells on cue representations
and utilize a new virtual-reality contextual fear conditioning task in order to determine the role of DG cue
representations on contextual memory discrimination behavior. Together, these experiments will help us better
understand the progressive transformation of information within the hippocampus during spatial navigation and
episodic memory, and how these processes may be defective in human cognitive disorders of learning and
memory.

Public health relevance
Project Narrative Defects in spatial navigation are an early sign of many forms of human dementia such as Alzheimer’s disease and mild cognitive impairment (MCI), and are thought to involve the dysfunction of neural circuits in the hippocampus- yet it is still unclear how different hippocampal subregions perform the neural computations that underlie spatial processing and episodic memory. In this proposal we will examine the integration of sensory cue (“what”) and spatial representations (“where”) in the first stage of hippocampal processing, the dentate gyrus, to elucidate the progressive transformation of information from the cortex to the hippocampus and how it is utilized in the formation of a cognitive map for spatial navigation and memory. Using modern in vivo population imaging and optogenetic techniques in mice to study neural circuits in the dentate gyrus during spatial and contextual learning, we believe the insights gained from this work will help us better understand, diagnose, and treat cognitive impairment in Alzheimer’s disease and other forms of dementia.